FISH OIL ON LIPID METABOLISM IN LIPODYSTROPHIC DIABETES MELLITUS

This study examines the effects of eicosapentanoic and docosahexanoic acids on plasma lipids, lipoproteins, and glucose metabolism in subjects with lipodystrophic diabetes mellitus.